RhoFED CDSMC

PROJECT SUMMARY/ABSTRACT
Type 1 diabetes (T1D) is a debilitating autoimmune disease in which the body attacks and destroys the
pancreas’s ability to make insulin. It can cause long term damage to or even failure of various other organs,
leading to irreparable injuries such as blindness, amputation, and stroke. The NIAID Clinical Data and Safety
Management Center (CDSMC) currently provides support for 2 T1D studies. This support includes safety
monitoring and reporting, data management, and randomization support, all of which are key components to
designing and conducting studies that answer research questions important to NIAID. Rho Product Safety
takes the lead on reporting serious adverse events occurring in participants enrolled in these studies, both to
NIAID and appropriate health authorities, to help ensure the safety of participants. Data management creates
and maintains data collection systems that support data entry and cleaning study clinical research data.
Randomization support is provided using fully validated, 21CFR11-compliant self-service web-based study
configuration interface that supports a variety of randomization schema.

Public health relevance
PROJECT NARRATIVE Characterized by an inability to create insulin, Type 1 diabetes (T1D) is a debilitating disease that can cause long-term damage to or even failure of various organs, leading to irreparable injuries such as blindness, amputation, stroke, and eventually death. These research funds would provide safety reporting, data management, and randomization support for studies investigating treatments for T1D in the Immune Tolerance Network (ITN).